Identifying Novel Roles and the Therapeutic Potential of the Thrombin Receptor Protease Activated Receptor-1 (PAR1) in Lung Lymphatic Function and Acute Respiratory Distress Syndrome

Project Abstract
Acute Respiratory Distress Syndrome (ARDS) is a devastating disease with high morbidity and mortality. The
COVID-19 pandemic and the yearly toll of viral and bacterial pneumonia underscore the urgent need for a
mechanistic understanding of ARDS that would lead to new therapies. ARDS is characterized by a prothrombotic
state and activation of the thrombin receptor protease activated receptor 1 (PAR1). PAR1 is perhaps the most
important mediator of inflammation and coagulation in ARDS, as it coordinates the interplay between platelets,
endothelial cells, and the immune response. However, targeting PAR1 therapeutically has thus far been
unsuccessful, highlighting our knowledge gaps in understanding the pleiotropic roles of this critical receptor. The
premise of proposal is that PAR1 plays a previously unappreciated role in the lymphatic vasculature in ARDS
that offers a novel therapeutic strategy to prevent lung injury. The lymphatic vasculature mediates the
inflammatory response of the lung through both fluid drainage and trafficking of immune cells. However, the
molecular pathways that drive these functions have not been fully uncovered. Lymphatics have specialized
endothelial cell junctions that mediate fluid and cell uptake into the vessel lumen. Loss of these permeable
‘button’ junctions impairs lymphatic function by preventing the drainage and cell trafficking function of these
vessels. Using mouse models, we have found that PAR1 is necessary for button junction formation during lung
injury. Lymphatic-specific loss of PAR1 leads to immune cell accumulation and worse lung injury, which our
studies suggest is due to loss of button junctions that promote lymphatic function. These data point to a
previously unknown role of PAR1 in lung injury that improves lymphatic drainage and promotes resolution of
inflammation. In this proposal, we will test the hypothesis that PAR1 is necessary for lymphatic buttons and
function (Aim 1), that thrombin-mediated PAR1 signaling in lymphatics is protective during lung injury due to its
role in promoting lymphatic buttons and drainage (Aim 2), and that agonists of PAR1 that promote beneficial
PAR1 signaling in lymphatics while persevering blood vessel function are a novel therapeutic strategy for ARDS
(Aim 3). When completed these studies will result in an entirely new paradigm for the pathogenesis of
ARDS by uncovering a link between PAR1, lymphatic function, and the inflammatory response, leading
to a novel therapeutic strategy for this devastating disease.

Public health relevance
Project Narrative Acute Respiratory Distress Syndrome (ARDS) is a devastating disease that can be caused by a variety of insults including COVID-19 and influenza, resulting in massive fluid and immune cell accumulation in the lungs that prevent breathing. The lymphatics are specialized vessels that are distinct from blood vessels and mediate both fluid drainage and movement of immune cells from the lungs. Here, we propose to investigate a novel mechanism that promotes lymphatic function and prevents lung injury, and to test whether this mechanism can leveraged to generate new therapies for ARDS.